1, 3-DIOL AND KETONE BODY METABOLISM

The long term goal is to devise new strategies for the treatment of nutritional diseases such as diabetes and specific inborn errors of energy metabolism. The specific aims: 1) to characterize the pharmacokinetics, metabolism, and safety of 1,3-butanediol diacetoacetate (ketone esters) in humans and its usefulness in patients suffering from pathologies which could be alleviated by therapeutic ketosis. 2) to devise a non-invasive clinical test to assess the activity ratio of pyruvate carboxylase; and pyruvate dehydrogenase in the liver of normal subjects and of children with inborn errors of pyruvate metabolism or diabetes. The labeled pyruvate studies have just begun with 4 studies in normal volunteers without any untoward events.